Genetic and molecular correlates of white matter pathology in Alzheimers disease

PROJECT SUMMARY: Although Alzheimer's disease (AD) is typically defined by the accumulation of beta-
amyloid and hyperphosphorylated tau proteins, synaptic loss and neuronal degeneration, the disease is not
restricted to the gray matter. Neuroimaging and neuropathological studies have documented a significant loss
of white matter in AD, which begins early in the disease course and is correlated with cognitive decline. In
addition to contributions of hypoperfusion-related ischemic injury and neurodegeneration-associated axonal
loss, emerging evidence indicates a decline and dysfunction of oligodendrocyte populations as additional
factors in this multifactorial white matter disease process. Oligodendrocytes are the most abundant glial cell
type in the brain, but are the least studied cell population in the context of neurodegeneration despite their vital
role for myelin maintenance and neuronal support. With the increasing recognition of the role of myelin in AD, it
becomes important to understand the genetic and molecular factors that link oligodendrocytes to the AD
process. Our knowledge about genetic variants contributing to overall AD risk and influencing AD-associated
endophenotypes is accelerating. Our proposal is designed to bring these two lines of investigation together and
begin to explore genetic modifiers of oligodendrocyte and myelin abnormalities in AD and underlying molecular
mechanisms using a quantitative trait approach of neuropathologically defined myelin endophenotypes.
The central hypothesis of our proposal is that loss of myelin integrity and oligodendrocyte
dysfunction in AD are associated with genetic variants and molecular changes. We will test this
hypothesis by first performing genome-wide association studies (GWAS) of white and gray matter
neuropathological endophenotypes in human postmortem brain tissue samples and will then conduct bulk and
spatially defined gene expression studies to explore underlying molecular mechanisms. Our experiments are
divided into two specific aims: Aim 1) To determine genetic modifiers of myelin and oligodendrocyte
pathologies in AD. Aim 2) To determine associations between white matter gene expression changes and
white matter pathologies in AD.
The above aims benefit from the tight integration and leveraging of a diverse group of investigators with
expertise in the neuropathology of AD and digitally quantified pathology endophenotypes (PI Kofler), AD-
associated oligodendrocyte pathology (Co-I Herrup), GWAS data analysis (Co-Is Kamboh and Fan),
biostatistical analysis of transcriptomics datasets (Co-I Ding) and digital image analysis and machine learning
(Co-I Pearce). Upon completion of our proposed studies, we will have identified novel candidate genes as
mediators of myelin pathology in AD, increased our understanding about the biology underlying their linkage to
AD and revealed novel targets for therapeutic interventions. As our study design includes separate analyses of
gray and white matter regions and stratification by sex, we will have further delineated regional and sex-
specific differences in myelin and oligodendrocyte pathobiology in the context of AD.

Public health relevance
PROJECT NARRATIVE: Alzheimer's disease is not restricted to the gray matter regions of the brain but also affects the white matter, and these changes contribute to cognitive decline. We propose to evaluate the contributions of genetic variants to the development of oligodendrocyte dysfunction and myelin integrity loss in Alzheimer’s disease using postmortem human tissue samples. We will then conduct gene expression studies to identify underlying molecular mechanisms.